Insights into Cognitive Resilience: Sleep, Physical Activity, and Neuroimaging Biomarkers in Aging and Preclinical Alzheimer's Disease

This Mentored Patient-Oriented Research Career Development Award (K01) application aims to equip the
candidate with the skills to establish an independent research program identifying modifiable lifestyle factors to
enhance cognitive resilience in aging and Alzheimer's disease-related dementias (ADRDs) and develop
neuroimaging measures to quantify these relationships. The proposed research will examine (1) actigraphy-
based measures of physical activity and sleep, and (2) network neuroimaging-based measures of functional
connectivity and microstructural integrity, as potential synergistic correlates of cognitive trajectories in older
adults and those with AD pathology accumulation. Recent published work by the candidate suggests physical
activity and sleep are synergistically related to better cognition and neuroimaging measures of functional
connectivity and microstructural integrity, and that these neuroimaging measures may reflect mechanisms of
cognitive resilience in aging and AD cross sectionally. This application proposes a longitudinal study to assess
i) whether physical activity and sleep are factors associated with cognitive resilience to AD pathology
accumulation over time, ii) if brain network connectivity and microstructure are neuroimaging correlates of
cognitive resilience to AD pathology over time, and iii) the association between physical activity and sleep with
functional connectivity and microstructure over time. With an excellent multidisciplinary mentorship team, the
applicants career development plan builds on his research training to gain experience in 1) AD pathology
biomarkers (specifically Positron Emission Tomography and Cerebrospinal Fluid), 2) actigraphy based
measures of physical activity and sleep, 3) longitudinal statistical analysis, 4) theoretical training in cognitive
resilience research and clinical knowledge of AD and related disorders, 5) professional development, and 6)
responsible conduct of research. The research objectives and training goals will foster an exceptional learning
environment, advancing the candidate's knowledge in cognitive aging and ADRD, ultimately facilitating their
transition to an independent investigator exploring the impact of modifiable lifestyle activities and brain
mechanisms underlying cognitive resilience in older individuals.

Public health relevance
PROJECT NARATIVE This integrated research study and training plan aims to investigate whether modifiable lifestyle factors, specifically sleep and physical activity, can enhance cognitive resilience to aging and the accumulation of Alzheimer’s disease (AD) pathology. It also seeks to utilize advanced neuroimaging methods to study these relationships, providing insights into individual differences in aging and early AD. The project includes training for the investigator to become an independent expert in the field, with the long-term goal of developing more effective and targeted interventions and biomarkers for promoting healthy neurocognitive aging.